Inflammatory Cytokine Networks in Gastrointestinal Tract Graft Versus Host Disease

Graft versus host disease (GVHD) is the major complication associated with allogeneic hematopoietic stem cell
transplantation (HSCT). During the acute phase of this disease, a restricted set of organs is affected of which the
gastrointestinal (GI) tract is the most clinically significant. Proinflammatory cytokines play a critical role in the
pathophysiology of intestinal GVHD, in part, by activating donor innate and T cell populations which
subsequently induce tissue damage. We previously demonstrated that CD4+ T cell production of granulocyte-
macrophage colony stimulating factor (GM-CSF) plays a critical inflammatory role in the pathophysiology of GI
GVHD. More recently, we have identified two CD4+ GM-CSF+ T cell populations within the GVHD colon
microenvironment that possess distinct transcriptional profiles, employ non-overlapping gene regulatory units,
emerge with divergent temporal kinetics, have differential responsiveness to IL-7, and are distinguishable by the
presence or absence of IFN-γ co-expression, suggesting that they may have different pathogenic roles in
mediating GVHD in the GI tract. In addition, our preliminary studies have uncovered a previously unappreciated
interleukin 34 (IL-34)-mediated regulatory pathway that inhibits the emergence of CD4+ GM-CSF+ T cells in
the GI tract, indicating the existence of a potential therapeutically targetable cytokine to reduce GM-CSF-
mediated inflammation in this tissue site. The overall goal of this proposal is therefore to delineate mechanistic
pathways by which CD4+ GM-CSF+ T cells promote pathological damage in the GI tract and define how these
populations are regulated by IL-34. Our overall hypothesis is that there exist discrete CD4+ GM-
CSF+ T cell populations that have distinct functional roles in mediating pathological damage
in the GI tract and that are regulated by the host production of IL-34. Studies in Specific Aim 1 will
define the pathogenicity of CD4+ GM-CSF+ T cell populations during GVHD. To address this question, we will
employ a recently created GM-CSF fate reporter mouse model that faithfully identifies viable GM-CSF-
expressing CD4+ T cells in GVHD target organs. Experiments in Specific Aim 2 will identify key transcription
factors and define the role of IL-7 in the development of CD4+ GM-CSF+ T cells. We will employ genetically
modified murine models that will ascertain the extent to which specific transcription factors are required for the
development and pathogenicity of CD4+ GM-CSF+ T cells and determine the dependency of these cells on IL-7
receptor signaling. Studies in Specific Aim 3 will characterize how IL-34 regulates GM-CSF-responsive innate
immune cell populations in the GI tract during GVHD and affects the emergence of CD4+ GM-CSF+ T cells.
Experiments will identify mechanistic pathways by which IL-34 regulates GVHD and determine whether these
pathways can be therapeutically targeted to reduce disease severity. The overall objective of this proposal is to
develop new insights into the pathophysiology and regulation of GVHD within the GI tract that will foster the
development of clinically relevant strategies to mitigate this complication in allogeneic HSCT recipients.

Public health relevance
PROJECT NARRATIVE Graft versus host disease (GVHD) of the gastrointestinal (GI) tract is one of the major complications associated with allogeneic hematopoietic stem cell transplantation (HSCT) and leads to significant morbidity and mortality. The goal of this project is to critically examine the role of an inflammatory cytokine, termed granulocyte- macrophage colony stimulating factor, in the pathophysiology of GVHD in the GI tract. The ultimate objective of this proposal is that, through these preclinical studies, we will gain new insights into this disease which will lead to the development of novel clinical approaches for the treatment of this complication after allogeneic HSCT.